Partnerships for Prevention: A plan for managing student stress, anxiety, and pain through interactive media.

The primary SEPA project is focused on anxiety and stress, which are incidental to everyone’s daily life. For
children and teens, learning how to navigate these challenges is critical to a healthy lifestyle, yet little is done in
school to teach students about these feelings and the underlying biology and physiology; a limitation that is
placing students at risk. Adding to what was already a growing trend in mental health challenges for students,
the COVID-19 pandemic of 2020/2021 created new stresses and anxieties. Our recent survey of student
stressors carried out pre-pandemic and repeated during the pandemic asked students about their stressors,
and also asked parent’s their perception of their children and teacher’s perception of their students. Among
other things, students scored their stress about the health of others 62% higher than what the parents
perceived the child’s level of concern to be. Similarly, students concern about their own health was 66% higher
than their parent’s perception. These data indicate that on top of all the stressors present in the lives of
students, they have added concerns about health issues associated with the pandemic, not the least of them
being anxiety over vaccination. Understanding science without a basic foundation can be intimidating for
students, families and teachers. This is especially true with the flood of miss-information on the web and social
media leading to mistrust. Unprepared, students are left with confusion that can fuel depression or other
mental health challenges. For example, recent studies by the CDC show that in 2021, nearly 1 in 5 students
age 12 to 17 were receiving mental health treatment. Countless more are undiagnosed and un-treated. In the
worst case, failing to address mental health challenges can negatively influence academics, sports, arts and
social interactions, possibly leading to depression and other mental health diseases including self-harm, opioid
use disorder or the tragedy of the disease of suicide. Our hypothesis is that understanding anxiety and stress
can be influenced by narrative-based educational stories for late elementary and middle school. Creating an
understanding of the biology of the brain, body and emotions plus developing healthy habits can set the stage
for preventative mental health resiliency providing benefits for now and for later in life. Using formative
assessment to better understand the world view of the student we develop an integrated collection of narrative
based, digital and analog multimedia including YouTube animated videos, Adaptive Reader stories and small
group, face-to-face table-top games. With illustrations of the fundamental biology underlying the physiology
and neural mechanisms of stress and anxiety the stories will reveal research-backed coping strategies and
how they can serve as the first line of defense, helping individuals to listen to their bodies to understand what
they can control, and also when it's time to seek professional advice. Each resource is further supported by
teacher guides, curriculum and student readings. This transmedia approach facilitates low barriers to use and
ease of entry through different modalities maximizing utility for the teacher or home schooler.

Public health relevance
Everyday pains, anxiety and stress are facts of life that most of us learn to manage and deal with, even though they are never taught to us in school. However, among students today there is an increasing struggle to cope, which is leading to elevated rates of mental health disorders including depression, addiction and even the disease of suicide. To create preventative resiliency, we are developing a collection of integrated digital and analog multimedia resources for late elementary and middle school students including YouTube animated videos, Adaptive Reader stories and table-top board games on the biology of the nervous system and healthy management techniques that address stress and anxiety present in the worldview of the students.